Novel systemic therapy to improve clinical outcome in small cell lung cancer

DESCRIPTION (provided by applicant): This candidate is an Assistant Professor in Hematology and Medical Oncology at Emory University. His long- term career goal is to become established as an independent translational researcher with recognized superior expertise in clinical care of lung cancer patients, conduct of clinical trials leading to the development of new treatment options for small cell lung cancer (SCLC) and in the preclinical evaluation of novel compounds likely to develop into effective therapy for SCLC. The candidate is interested in advancing the care and clinical outcome of SCLC patients by investigating new treatment options and developing effective strategies to improve on the efficacy of currently available therapies. The candidate has proposed a career development plan that includes a multi-faceted training and mentoring program designed to provide an intense, patient- oriented research experience. These goals will be achieved through his lead role in the design and conduct of two clinical trials enrolling SCLC patients. The first trial is a single institution study designed by he candidate that will evaluate the clinical efficacy of arsenic trioxide in relapsed disease. If successful, this clinical trial will introduce a novel therapy into the treatment options for the refractory patient population. The second clinical trial is a direct translation of the candidate's preclinical laboratory work designed to evaluate whether the addition of ABT-888, an orally administered PARP inhibitor, will enhance the efficacy of standard chemotherapy agents without increased toxicity in newly diagnosed SCLC patients. This study is planned as a multi-institution clinical trial to be conducted through the established cooperative group mechanism of ECOG. Additionally, in preparation for a long term career as a translational scientist, the candidate proposes the establishment of a SCLC tumor bank by xenogeneic transplantation of tumor samples to immunodeficient mice during this period of mentored training. This unique resource will support ongoing and future preclinical evaluation of new anticancer agents and facilitate the understanding of the unique biology of SCLC. Simultaneous with this intense practical experience in patient-oriented research, the candidate will participate in a formal well-structured didactic curriculum leading to the award of a Masters of Science in Clinical Research from his home institution, Emory University. This course of study is a rigorous multi-year curriculum designed to provide participants with a deep knowledge and comprehensive understanding of the ethics, design, conduct and regulation of patient-oriented research. This overall training and practical experience will occur under the lead mentorship of Dr. Fadlo Khuri, an accomplished translational researcher with track record of successfully mentoring all cadres of clinicians and basic scientists. He will be assisted by co-mentors with complementary expertise including Suresh Ramalingam, MD, an internationally renowned clinical investigator with superb expertise in lung cancer; Shi-Yong Sun, PhD, a highly experienced basic scientist and a world leader in mTOR biology; and Mourad Tighiouart, PhD, a biostatistician with strong interest in design of clinical trials to evaluate promising anticancer agents. This training program will occur at Emory University and the Winship Cancer Institute of Emory University which provide an ideal environment for learning, training and practical exposure in patient-oriented research and a unique opportunity for collaboration between basic scientists and clinical investigators. The Winship Cancer Institute is an NCI-designated cancer center which ensures the proper conduct of investigator-initiated single center studies as well as participation in large cooperative group clinical trials as proposed in this application. It is expected that at the end of this mentoring period, the candidate will be adequately prepared to pursue an independent research career focused on SCLC and will be highly competitive for research funding and academic leadership roles.

Public health relevance
Project Narrative: Candidate plans to advance the care and clinical outcome of small cell lung cancer by investigating new treatment options and developing an effective strategy to improve on currently available therapies through clinical trials for small cell lung cancer and in preclinical evaluation of novel compounds with potential to develop into effective therapy for lung cancer __SpecificAimsTextDelimiter__ 10. Specific Aims: Small cell lung cancer (SCLC): SCLC constitutes approximately 15% of all cases of lung cancer, which translates to 30,000 new cases in the US and almost 200,000 new cases worldwide each year.5,6 While it is a chemosensitive disease in the frontline setting, it is a highly fatal disease with very poor long term overall outcome. Currently available frontline regimens achieve an objective response in approximately 50-70% of patients with extensive SCLC but the median survival is only 10 months, and the 2-year survival rate can be as low as 2.2%.6 There have been no significant improvement in the outcome of SCLC therapy in the last 20 years and no major therapeutic discovery in the last decade. Unlike patients with newly diagnosed disease, the clinical course is especially bad for patients with relapsed disease, which is poorly responsive to salvage therapy. The biological basis for the high rate of disease relapse and the poor response of relapsed disease to salvage therapy remains poorly understood. Using a three-pronged approach to develop novel treatment options, enhance efficacy of established therapeutic agents and improve understanding of disease biology, this career development grant application will support the candidate's vision to become established as a translational scientist with particular focus on SCLC. The following specific aims will be addressed as part of the candidate's research and career development plan. Specific Aims: Aim 1: Conduct a phase II clinical trial of arsenic trioxide as salvage therapy in SCLC This proposal will evaluate a novel therapeutic approach with a differentiating agent in the relapsed disease setting. The mortality associated with SCLC is driven mainly by the resistance of relapsed disease to conventional cytotoxic agents. This trial is an investigator-initiated trial, conceived and designed by the candidate. The study will enroll up to 33 patients with relapsed SCLC to test the hypothesis that a cytotoxic differentiating agent, arsenic trioxide, will confer clinical benefit in patients with relapsed SCLC. In order to minimize overall study size, a Simon 2-stage design will be employed to establish the efficacy and to minimize patient accrual if the investigational agent has no significant clinical benefit in this patient population. The PI has obtained industry support for drug supply from the manufacturer (Appendix I). He also secured intramural funding from the cancer center to support clinical trial-related expenses (Appendix II). It is anticipated that arsenic trioxide therapy will result in objective responses and improved disease control in relapsed SCLC. Aim 2: Conduct a randomized, multicenter phase II trial of cisplatin/etoposide in combination with placebo or in combination with ABT-888 as first line therapy in extensive stage SCLC PARP inhibitor potentiates the activity of DNA damaging agents in the preclinical and clinical setting. The proposed trial is a direct clinical translation of the preclinical work conceived by the candidate and conducted in his laboratory at the Winship Cancer Institute. ABT-888 is an inhibitor of the DNA damage repair enzyme, PARP. It potentiates the cytotoxic effect of cisplatin and etoposide in vitro and results in enhanced growth inhibition by cisplatin in SCLC xenografts. This randomized study will enroll up to 150 patients with newly diagnosed extensive stage SCLC. Patients will be randomized to standard chemotherapy (cisplatin/etoposide) with placebo or standard chemotherapy plus ABT888. This study will be conducted as a multicenter trial using the resources and mechanisms of the Eastern Cooperative Oncology Group (ECOG). This study has received formal approval from the ECOG Thoracic Core Committee (Appendix III). The addition of ABT-888 to frontline chemotherapy is expected to result in improved efficacy leading to superior progression free survival in patients treated with ABT-888. Aim 3: Establish SCLC heterotopic xenotransplants as a platform for preclinical drug testing and in depth study of SCLC biology Improved outcome for SCLC requires a better understanding of the biology of this disease. Surgical resection is no longer a standard therapeutic approach. Hence, a vast majority of SCLC cases are diagnosed through less invasive techniques of fine needle aspiration biopsy. This paradigm shift has curtailed basic and correlative research with the consequent lack of therapeutic advance in SCLC due to limited availability of tissue samples to interrogate tumor biology. The use of direct tumor heterotopic xenotransplants has been shown to be a reliable platform for the study of tumor biology. The candidate plans to establish a tumor bank of SCLC using direct tumor transplants from up to 20 patients with newly diagnosed or relapsed SCLC. This will serve as continual source of biologic material and will support the candidate's vision of a career in translational research in this patient population. The candidate spent several days in the laboratory of Dr. Funda Merric- Bernstam at the MD Anderson Cancer Center to obtain direct hands-on training in this technique.